Mechanisms driving cell fate specification and morphogenesis in the blastocyst

PROJECT SUMMARY / ABSTRACT
Understanding the molecular logic that configures interactions between the transcription
factors and signaling networks that guide the development of an entire organism is arguably
one of the major challenges of modern biology, and as such, it needs good experimental
systems. The mammalian blastocyst is one such system.
Preimplantation mammalian embryo development - from the fertilized egg to the blastocyst
stage - offers a simplified and tractable model for investigating the coordination of cell fate
specification and morphogenesis at single-cell resolution across a population. The
blastocyst is a universal mammalian developmental stage and a paradigm of tissue self-
organization. Preimplantation embryo development involves two sequential binary cell fate
decisions that give rise to three cell lineages: the pluripotent epiblast (EPI) which is the
founder tissue of almost all somatic cells, and two primarily extra-embryonic lineages, the
trophectoderm (TE) and primitive endoderm (PrE). The three cell lineages of the blastocyst
are defined by their position, developmental potential, and marker expression. Gaining
insight into the mechanistic underpinnings of cell fate specification within the blastocyst,
builds on our previous findings, and is the subject of this R01 grant application.
The overarching goal of this project is to exploit mouse genetic and embryological methods
with single-cell resolution quantitative approaches, to understand how the pluripotent
epiblast (EPI) and primitive endoderm (PrE) lineages of the blastocyst form in time and
space.
By live imaging EPI and PrE cells as they emerge within the ICM population, we will
determine the dynamic cell behaviors driving lineage divergence within the ICM in
SPECIFIC AIM 1. To delineate the gene regulatory network driving these alternate fate
decisions, we will investigate the roles of NANOG and GATA6, the two transcription factors
positioned at the apex of the network in SPECIFIC AIM 2. FGF4 is the secreted signal
driving lineage divergence within the ICM and promoting EPI maturation. In SPECIFIC AIM
3 we will visualize cells transducing the FGF4 signal and investigate downstream
components of the FGF4 signaling cascade operating in the ICM. Since cell fate
specification across the ICM population is only complete concomitant with cell sorting, in
SPECIFIC AIM 4 we will seek to determine whether a cell's position impacts a its fate
choice.
!

Public health relevance
PROJECT NARRATIVE / PUBLIC HEALTH RELEVANCE The overarching goal for this project is to understand the molecular events governing the earliest stages of mammalian development. Specifically, we will use the mouse as an experimentally tractable mammalian model system to investigate how a universal stage of mammalian development – the blastocyst - forms. An in depth mechanistic understanding of critical events taking place during mouse development will provide the essential foundation for understanding the origin of human birth defects. Moreover, decoding the mechanics of cellular communication and their role on cell fate decisions will be a guiding light in the development of methods for directing cells towards distinct identities with therapeutic potential. !